Short term training for veterinary students

Project Summary
The purpose of the training program outlined in this renewal application is to provide short-term intensive research
experiences to professional veterinary medical students. The short-term goal is to stimulate an interest in the pursuit
of hypothesis-based research that examines mechanisms, treatment, and prevention of disease. The long-term
goal is to increase the number of veterinary students who embrace research as part of their career, with a focus
that ranges from basic science/discovery to translational and epidemiological studies. These individuals fill a unique
niche in the biomedical community, combining a comparative medical education with investigatory skills that are
essential to advancing human and animal health. The program is based upon a research intensive summer
experience that is part of a larger Summer Research Program. First- and second-year veterinary students select
mentors from graduate faculty with primary appointments in Ohio State's Colleges of Veterinary Medicine, Medicine
and Pharmacy. This assures broad exposure of students to all facets of the health sciences community. Projects
are developed in collaboration between student and mentor, assuring the project reflects student interests and
ideas. Development of the proposal and preliminary training activities occur prior to summer, and presentation and
publication of research results are emphasized in the period following summer. The latter includes an end-of-
summer research symposium, where students make oral presentations of research results, and poster/platform
presentations at the CVM Research Day the following spring. Participating students are selected from within the
OSU CVM community. The most meritorious projects are selected based upon proposals submitted to and ranked
by the CVM Council for Research, with final award decisions made by the Executive Steering Committee of the
Summer Research Program. This approach maximizes quality of students and projects, with an average of 30
applications for 10 T35 positions. The faculty mentor:student ratio is 3:1, providing a large number of training
options that ensures a fit with student interests. We have a formal process for obtaining student feedback and as
a result, summer seminars are increasingly focused on career development. As part of this effort, we now provide
summer research students the opportunity to engage in a Rainier Scholars Program that positions them for careers
in industry. Combined with panel discussions involving graduate students, post docs, faculty and veterinary
researchers in government, the exposure to potential research careers is comprehensive. Subsequent pursuit of
graduate education is a leading indicator of program success. Of the 60 T35 trainees who have completed their
DVM, 48% have or are currently engaged in graduate education, this being a strong foundation for research-
oriented careers.

Public health relevance
Project Narrative The research experience supported by this training grant will enhance recruitment of DVMs into graduate programs or other research career tracks, thereby addressing the national need for veterinary scientists who are an essential component of our biomedical research force.